Transient Receptor Potential Ion Channels and Corneal Defense Against Bacterial Adhesion

Project summary/Abstract:
Pseudomonas aeruginosa and Staphylococcus aureus are the two most frequent causes of sight-
threatening bacterial keratitis in the USA. Infections caused by either pathogen can be difficult to treat,
complicated by the ever-evolving problem of antibiotic resistance. Even successful treatment does not
always prevent scarring and associated vision loss. Importantly, the healthy cornea is infection resistant,
able of avoid adhesion by virtually all pathogens, including large inocula of P. aeruginosa or S. aureus. For
over three decades, our lab has focused on understanding this intrinsic resistance to infection, and how its
compromise by predisposing factors sets up conditions for infection initiation, focusing on both the cornea
and the bacteria. The outcomes have contributed substantially to our knowledge about those topics.
The cornea is endowed with a high density of sensory nerve endings, including some polymodal by
virtue of their Transient Receptor Potential (TRP) cation channels. These are mostly TRPV1 (Vanilloid),
with TRPA1 (Ankyrin) present only on a subset of TRPV1 expressing nerves. Recently, we reported that
corneal nerves can modulate the healthy cornea’s susceptibility to bacterial adhesion involving TRPV1 and
TRPA1. Our new data show that these two receptor types confer selectivity for pathogen type, with only
TRPV1 countering S. aureus adhesion, and TRPA1 instead countering P. aeruginosa - only the latter
requiring nerve firing. We further report that while inoculation with either pathogen elicits a TRPV1/A1 and
nerve dependent immune cell response, the details differ. P. aeruginosa increases numbers of CD45+ and
CD11c+ cells, the CD11c+ cell fraction shifting to being less spherical and closer to the corneal surface.
Importantly, the CD11c+ cells contribute to countering bacterial adhesion. S. aureus causes a smaller
CD45+ cell response, with no increase to CD11c+ cell numbers, and different changes to immune cell
morphology and location - including a shift away from the corneal surface.
Here, we aim to better understand how TRPV1 and TRPA1 differentially counter S. aureus and P.
aeruginosa adhesion to the healthy murine cornea. Thus, we will compare them more thoroughly for
contributions of immune cells (aim 1), direct-acting players at the ocular surface (aim 2), and roles of
bacterial ligands (aim 3). The approach will include use of multiple state-of-the-art technologies including
flow cytometry in aim 1, and high-resolution mass spectrometry and snRNAseq in aim 2. All three aims
have potential to yield novel strategies for preventing infection before pathology and the associated risk of
vision loss begins. Meanwhile, they will advance our general understanding of the healthy cornea’s
response to microbial challenge, the relationship to neuroinflammation, roles of nerves, TRPA1 and TRPV1
in the cornea, and the biology of the ocular surface and tear fluid.

Public health relevance
Project narrative: Bacterial infections of the cornea, potentially devastating to vision, are becoming more common and more difficult to treat due to ever-evolving resistance to antimicrobials. We have discovered that infection resistant healthy corneas can utilize their sensory nerves to protect against bacterial binding, involving two receptors able to discriminate between pathogen types while having different impacts on corneal immune cells. Here, we aim to understand the mechanisms involved, our long-term goal being to develop strategies for preventing infection before it begins.